CORE--GLASSWARE RESOURCE

Glassware Services is responsible for cleaning and sterilizing reusable laboratory glassware on a timely basis. Procedures are routinely available to all laboratories on the Hutchinson South Lake Union campus, and include washing, drying and sterilization of glassware, pipette plugging and autoclaving of laboratory liquids. Designated personnel within the facility are responsible for processing and sterilization of biohazardous waste from all laboratories, and the coordination of a pipette tip program. The resource continues to maintain its College of American Pathology accreditation for clinically related investigation. This application requests continued support for a resource which continues to fulfill an essential role for peer reviewed research.